STUDY OF OCTREOTIDE IN THE MANAGEMENT OF NEUROENDOCRINE TUMORS

Evaluate the antitumor effect of octreotide at maximally tolerated doses against carcinoid and pancreatic islet cell tumors. Determine the specificity of octreotide's inhibitory effect in a dose/response relationship on the endogenous release of neuroendocrine tumor products.